The Role of Early Life Exposure to Antibiotics on Risk of Early Onset Colorectal Cancer

PROJECT SUMMARY/ABSTRACT
The incidence of early onset colorectal cancer (EOCRC) has increased in the past four decades and is
predicted to increase by 140% by 2030.4,5 It is the second most common cancer and third leading cause of
cancer deaths in individuals under 50 years old in the USA.4,6,7 In a recent review47, we proposed that increased
risk of EOCRC is driven by exposomes whose entry into the global environment precedes and mimics the
worldwide increase in EOCRC incidence. Exposure to these suspected exposomes has been increasing in the
past 40 years (as has EOCRC), and they all impact guardians of the colon (inflammation, the microbiome, and
epigenetic/genetic changes); exposure is global and occurs during development – potentially during childhood.
In this project, we focus on the role of exposure to antibiotics during development and its on impact EOCRC in
appropriate pre-clinical models. Antibiotic overuse has become a serious public health concern, with over a
million doses prescribed annually in the US.50,23 Its use in infants is high; over 50% are directly exposed for >5
days.17 Indirect exposure in pregnancy affects infant gut microbiota at birth19,20; and at an early age, exposure
can lead to multiple health disorders - including CRC.21,22,23 Repeated exposures contribute to antibiotic
resistance and altered gut microbiota with pro-inflammatory and pro-carcinogenic outcomes28-32, suggesting that
there may be windows of developmental vulnerability. However, epidemiologic and animal studies have shown
conflicting results, with none conducted on the impact of antibiotics commonly prescribed to infants and children
on the colon, creating a substantial gap in our knowledge on the mechanisms by which antibiotics impact
EOCRC. We will address this gap by testing the hypothesis that exposure early in life to antibiotics commonly
prescribed to children causes a toxic colon (associated with dysbiosis, inflammation, and altered genetic
signatures) that promote mutations leading to EOCRC. Using mouse models of CRC, we will test this hypothesis
in two specific aims: Aim 1. To identify developmental windows of susceptibility to antibiotics; Aim 2. To
determine if dysbiosis caused by antibiotics drives EOCRC. Upon completion, we will know: (1) the impact of
antibiotics on EOCRC risk; (2) developmental windows of colon susceptibility to antibiotics; (3) what microbes
drive EOCRC; and (4) whether these microorganisms promote increased mutation as a mechanism causing
CRC. The acquired knowledge will be critical in developing novel strategies to identify individuals at risk,
interventions to minimize risk of EOCRC, and informed decisions to mitigate risk after use of antibiotics that are
indispensable against infections, and more importantly, provide the foundation for future studies to identify
components of human microbiome that mediate increased risk for EOCRC.

Public health relevance
PROJECT NARRATIVE The overarching goal of our research is to determine the causes and elucidate the mechanisms of early onset colorectal cancer (EOCRC). In this proposal we will test the hypothesis that early life exposure to commonly used antibiotics will alter the gut microbiome and inflammatory microenvironment to increase the risk of EOCRC, using preclinical models. The results from these studies will allow us to identify developmental stages of susceptibility to antibiotics, inform the development of novel strategies to identify high risk individuals and interventions to minimize risk of EOCRC, make informed decisions on how to mitigate the deleterious effects of antibiotics that are indispensable for fighting infections, and provide the foundation for future studies to identify components of human microbiota that mediate increased risk for EOCRC.